Predicting epilepsy surgery outcomes from individualized resting state functional anomalies

Project Summary/Abstract:
This proposal details a 5-year plan to provide the candidate, Dr. Taha Gholipour, with the knowledge
and expertise to become an independent investigator. He is a board-certified neurologist and
epileptologist with research training in neuroimaging. The candidate's training will be guided by
established mentors with expertise in the field of epilepsy research, functional imaging, advanced
statistics and machine learning, and an advisory committee of scientists with collective expertise in
clinical neuroscience and image analysis across prominent institutions. Uncontrolled seizures from
epilepsy are associated with high morbidity, mortality, and cost. Current clinical and imaging predictors
of response to surgery are inadequate, and surgical treatment outcomes are mixed. Predicting
treatment outcome is critical for clinical decision making. Functional MRI (fMRI) offers noninvasive and
accessible means for assessment of brain networks and may complement current methods of surgical
planning to guide treatment. Statistical constraints from abundance of variables and data heterogeneity
in fMRI analysis can be addressed by application of novel statistical and machine learning methods.
The candidate will conduct a study with retrospective analysis of large multicenter datasets of resting
state fMRI studies from adult and pediatric focal epilepsy patients, and a prospective arm to identify
preliminary predictors of treatment response to guide future multi-site studies. The candidate will use
functional anomaly mapping method to identify associations of this method with commonly used
functional connectivity analysis and treatment outcomes 12 months after surgery. Post-surgical
resection masks, clinical outcomes of seizure control and cognitive decline from surgery are collected in
prospective arm. The goal is to identify common features in patients who become seizure-free following
surgery. This study will use innovative methods to improve non-invasive evaluation of patients with
refractory epilepsy, which can expand surgical candidacy for patients with or without apparent lesions
on MRI. This project aims to help overcome current barriers to personalized care for people with
epilepsy. The innovative use of advances statistics for solving clinical challenges in epilepsy imaging
will have a fundamental impact on designing future investigations focused on developing biomarkers,
predicting response to treatment, and understanding the disease mechanisms in epilepsy, as
advocated by the 2021 AES/NINDS Epilepsy Research Benchmarks.

Public health relevance
Project Narrative Existing methods of predicting response to surgical treatment based on patient's clinical and imaging characteristics are inadequate for guiding personalized treatment of pharmacoresistant epilepsy and ameliorating its high burden in adults and children. This proposal uses advanced analytic methods with a novel network-based approach to derive predictors of outcomes from non-invasive and accessible functional brain images. The results of this proposal will guide future studies and advance the field toward developing biomarkers, predicting response to treatment, and understanding the disease mechanisms in epilepsy.